Vascular Mechanisms of Hypertensive Nephropathy

Hypertensive nephropathy is a common cause of chronic kidney disease (CKD) and is the
second leading cause of end-stage kidney disease (ESKD). The prevalence of CKD is
significantly higher than the general population and demonstrate progressive loss of kidney
function over time, more attention to the underlying mechanisms of hypertensive nephropathy
are required. Remodeling of the afferent arterioles and accompanying glomerulosclerosis are
hallmarks of human hypertensive nephropathy. Despite extensive investigation, there remain
gaps in understanding why some hypertensive patients develop ESKD, while others do not.
The molecular pathogenesis of the arteriolar remodeling in hypertensive nephropathy would
provide clues to this susceptibility, but the multiple variables that associate with the human
condition limit the ability to provide definitive conclusions. Insight into the molecular basis of
renal microvascular remodeling may therefore be gained through the study of relevant animal
models, in particular the Dahl salt-sensitive (SS) rat, a well-characterized model of hypertensive
nephropathy. Our previous studies, which are described in detail in this application, uncovered
an intrinsic defect in the structural/functional relationship of the renal microvasculature of SS
rats occurring with increases in blood pressure. Preliminary and published studies revealed that
hypertension rapidly upregulated expression of both matrix metalloproteinase-9 (MMP-9) and
Chemokine (C-C motif) Ligand 2 (CCL2), a potent pro-inflammatory chemokine, in kidney
microvasculature of SS rats. We further confirmed that ED-1-positive macrophages collected
around the microvessels of hypertensive SS rats. Our combined findings support the working
hypothesis that hypertension-induced kidney disease in SS rats is initiated by glomerular
injury mediated by microvascular smooth muscle production of a milieu that promotes
inflammation, remodeling, and autoregulatory impairment (Fig. 1). We propose 2 aims:
Aim 1: Determine the novel mechanisms of renal microvascular remodeling and autoregulatory
dysfunction in SS rats. Hypothesis: MMP-9 mediates afferent arteriolar remodeling and
impairment of the myogenic response during the development of hypertension.
1.1 Assess renal afferent arteriolar remodeling and autoregulatory behavior and smooth
muscle pathobiology of SSMmp9-/- rats.
1.2 Describe the role of kidney-specific versus systemic expression of MMP-9 in
microvascular remodeling using a kidney transplant model.
Aim 2: Define the mechanisms of the renal microvascular inflammatory process on
hypertensive nephropathy in SS rats. Hypothesis: CCL2 is integrally involved in renal
microvascular remodeling and autoregulatory impairment in hypertensive SS rats.
2.1 Describe the role of CCL2 in microvascular inflammation and autoregulation in
SSCcl2-/- rats.
2.2 Determine the microvascular mechanism of kidney-specific versus systemic
expression of CCL2 in hypertensive nephropathy using a model of kidney
transplantation.
By focusing on the molecular pathogenesis of renal microvascular inflammation and remodeling,
impaired autoregulatory response to hypertension and glomerular injury, these studies will
improve understanding of the molecular basis of CKD and ESKD from hypertension.

Public health relevance
Hypertension afflicts more than 30% of the adult population and is one of the most common causes of progressive chronic kidney disease (CKD) in the US. There is a disproportionate increased prevalence of CKD in veterans compared with the general population and nearly half have hypertension. The percentage of hypertensive patients who ultimately develop ESKD has remained constant despite treatment. The present application proposes to fill gaps in understanding how the microvasculature of the kidney is predisposed to hypertension-induced changes that lead to detrimental arteriolar remodeling, accompanying glomerular injury, and development of progressive CKD.